Deciphering Genetic Susceptibility of Pemphigus through Immunomics

ABSTRACT
Pemphigus is a broad term denoting a subset of potentially life-threatening autoimmune blistering skin diseases
with a prevalence of 5.2 cases per 100,000 adults in the United States. Pemphigus foliaceus (PF) is a unique
disease intimately related to environmental factors that trigger the disease in genetically susceptible individuals
residing in endemic areas, including hematophagous insect bites. Among the genetic variants strongly
associated with PF risk are those located within the major histocompatibility complex (MHC), such as the human
leukocyte antigen (HLA) class I and II genes. The PI has over a decade of experience in studying this disease
and deciphering the unusually complex variation of the extended MHC in multiple populations. The overall goal
is to apply a multi-omics approach to perform the most precise mapping of the extended MHC variation and its
genetic associations in pemphigus. We will apply long-read high-fidelity large scale to sequencing the entire 5
Mbp extended MHC in pemphigus and use long-read single-cell RNA sequencing (scRNA-seq) to analyze the
expression profiles in patients and controls, as well as to perform the first eQTL (expression quantitative traits
loci) mapping of the extended MHC using long-read scRNA-seq. We will reveal MHC genetic variants that affect
gene expression at the single-cell level and functionally demonstrate disease mechanisms. We will also use
scRNA-seq to access the T-cell repertories of patients and controls from endemic areas, which, in the context of
MHC variation, is a powerful tool for searching for disease mechanisms and therapeutic targets. Finally, we will
apply multiple massively parallel phage sequencing assays in sera samples to measure antibody response and
discover reactive antigens associated with pemphigus. We are particularly interested in identifying novel human
autoantigens that might affect the disease and viral antigens that could trigger this disease in the endemic areas.
This unprecedented immunomics approach will significantly advance the understanding of genetic associations
of PF, in addition to discovering new disease mechanisms and possibly new treatment options. As autoimmune
diseases often share genetic associations, our findings can possibly be extended to other diseases. Similarly,
mapping the functional variation of the MHC will allow a broader understanding of the immune system. If viral
antigens are identified as PF triggers, we may pinpoint a direct mechanism for disease prevention, marking a
significant step forward in addressing the health disparities associated with this neglected disease.

Public health relevance
NARRATIVE Pemphigus is an autoimmune blistering skin disease that occurs sporadically across the globe but is triggered by still unknown environmental antigens in endemic areas. Although its etiology is poorly known, it has been demonstrated that the variation of the extended major histocompatibility complex (MHC) is strongly associated with a differential risk of developing pemphigus. Here, we will apply State-of-the-Art multi-omics approaches to discover causal variants, reactive antigens, and disease mechanisms.